Research Supplements to Promote Diversity in Health-Related Research (Admin Supp)

Project Summary
This supplement will fund an undergraduate in our lab to conduct research on the potential usage of block
copolymers for creating distinctive textures in tactile aids. This program would directly improve the
participation of people from underrepresented groups in research and prepare them for future graduate-level
work.

Public health relevance
Project Narrative Block copolymers, when poured into a film, make unique nanostructures. We are exploring if these nanostructures can lead to distinctive tactile sensations in a tactile aid, which would expand the toolkit for designers of tactile aids and benefit users who are blind or severely visually impaired.